G-RISE at Delaware State University: Diversifying neuroscience through predoctoral training at an HBCU

Diversifying neuroscience through predoctoral training at an HBCU
Delaware State University (DSU), a Historically-Black university with an emerging strength in
neuroscience research proposes a G-RISE program focused on predoctoral training in neuroscience. Our
interdisciplinary program will support a diverse group of students in our Neuroscience PhD program. Our
young PhD program has produced 10 graduates, six from underrepresented groups and half of them
African-American. With our G-RISE project we will build on our record of graduating diverse
neuroscience doctorates, while addressing weaknesses identified by our program self-assessment – a small
pool of qualified applicants and a low rate of publications among program students.
Our G-RISE support program will link students in Neuroscience PhD program into a supportive,
research-rich community that will provide extensive professional and skills development including: 1) A
two-semester, 3-credit Professional Development course with a focus on responsible conduct of research,
ensuring rigor in research, diverse career pathways, and writing both NSF and NIH fellowship grant
proposals; 2) A weekly RISE seminar that will build cohort cohesiveness and strengthen students’
professional skills and their understanding of how to do rigorous science; 3) Quantitative skills and
Scientific Writing courses to provide more support to students in two areas where they are challenged; and
3) a formal program induction/orientation and enhanced mentoring by culturally-competent mentors. The
professional development course grant writing and extensive mentoring will help the students to develop
their identities as professional scientist, while the scientific writing course will provide the support to get
them published. Grounded in the literature, these strategies will both provide the G-RISE students with
strong academic support, and all of the project components are sustainable and transferrable to other schools
and programs. The Evaluation Plan includes focus groups for summative assessment and validated, baseline
and follow-up surveys to assess the development of participants' self-efficacy (research and academic) and
identities as scientists and researchers.
The number of PhD graduates in neuroscience has grown rapidly since the beginning of the century,
and currently over 700 neuroscience doctorates are awarded annually, but only about 20 each year awarded
to African-Americans. Currently, DSU is the only HBCU that awards the PhD in neuroscience, so
supporting and strengthening its program to produce 3 – 4 neuroscience PhD graduates each year will have
a significant impact on the diversity of the doctoral workforce.

Public health relevance
Public Health Relevance Today’s biomedical researchers represent the backbone of innovation that improves public health nationwide. However, they have little resemblance to the America’s increasingly diverse populations which contributes to disparities in health access and outcomes. The proposed project to establish a G-RISE site at Delaware State University (DSU) will promote diversity of the new workforce in biomedical research. Being a Historically Black University, DSU is well positioned to significantly contribute towards this goal as its Neuroscience PhD program graduates are 60% among minorities underrepresented in the biomedical research workforce.